Regulation and Function of respiratory mucosal immunity post SARS-CoV-2 vaccination and infection

Current intramuscular COVID-19 vaccines, despite eliciting robust systemic immune responses, generate
suboptimal neutralizing antibody (nAb), IgA Ab, and cellular responses in the respiratory mucosal. This is
likely why current vaccines are less effective at preventing infection and transmission. The role of mucosal
immunity in protecting against respiratory viral infection remains largely unexplored. The long-term goal of
this research is to comprehensively understand the differentiation, function, regulation, and interaction of
respiratory immune cells. Pilot data revealed that people with hybrid immunity from SARS-CoV-2 infection
and vaccination exhibit significantly high levels of antigen-specific IgA and nAbs in the respiratory mucosa,
compared to those who got vaccinated or infected alone. Further, recent research and our initial findings
suggest that mucosal IgA is locally produced by lung-resident B cells during both primary infection and
reinfection, yet the specific role and development of mucosal IgA are not fully understood. Therefore, the
overall objectives of this application are to a) understand systemic and mucosal immunity in people with
hybrid immunity, b) define immune compartments that confer protection and transmission in animal models,
and c) unravel the mechanisms underlying the respiratory protection of mucosal immunity. The central
hypothesis is that respiratory IgA provides neutralization and protection against heterologous infection,
facilitated by an orchestrated interaction between macrophages, CD4 Th1 cells, and IgA+ B cells in the
respiratory mucosa. This hypothesis will be tested by pursuing three specific aims: 1) To identify the
respiratory mucosal immunity in people with hybrid immunity, 2) To study protection and transmission
following SARS-CoV-2 breakthrough infection or mucosal vaccine booster in animal models primed with
mRNA vaccines, and 3) To elucidate the mechanisms underlying the mucosal protection of respiratory
immunity. Aim 1 will systematically profile the immune signatures in the blood, nasal cavity, and lower
airway in children with hybrid immunity. Aim 2 will utilize mouse and hamster models of hybrid immunity and
mucosal vaccine booster to study protection and transmission. Under Aim 3, we will investigate the
mechanism of mucosal protection in both humans and mice. This research will advance our understanding
of respiratory immunology and vaccinology, potentially impacting the global fight against SARS-CoV-2 and
future respiratory viruses. This project will provide the applicant, Dr. Jinyi Tang, with experimental and
conceptual training to develop his research program and ensure his transition to an independent tenure-
track position. Dr. Tang will be mentored by a committee of experienced immunologist, virologist and
clinician-scientist specializing in mucosal viral immunology, led by primary mentor Dr. Jie Sun. The planned
career development activities will ensure Dr. Tang achieves his long-term goals of consistent manuscript
publishing, achieving independent funding, and training of the next generation of scientists.

Public health relevance
This research investigates the critical yet understudied role of respiratory mucosal antibody and cellular immunity in response to SARS-CoV-2 reinfections and transmissions. The research aim is to unravel the orchestrated interaction among respiratory macrophages, T cells, and B cells in regulating mucosal IgA production, which provides frontline neutralization and protection against SARS-CoV-2 heterologous infection. This work is expected to significantly enhance our understanding of respiratory immunology and vaccinology, enabling the development of next-generation mucosal vaccines that could impact the global fight against SARS-CoV-2 and future respiratory viruses.